Adolescent exposure to PCBs as a risk factor for the development of depression

ABSTRACT
This proposal addresses an urgent need to understand and analyze the impact of environmental factors
on the development of psychiatric diseases, such as depression. Adolescents are particularly vulnerable
to both developing depression and health impacts of environmental exposures. Emerging evidence
suggests that exposure to polychlorinated biphenyls (PCBs) may influence the risk of depression. PCBs
are highly pervasive in the environment and biota due to their widespread use, careless disposal, and
resistance to degradation. Moreover, recent data demonstrates widespread human exposure to, not only
legacy, but also “contemporary” PCB congeners that are unintentional byproducts of current manufacturing
processes. A widespread PCB contamination has been identified in schools, highlighting the importance
of evaluating the role of PCB exposure on the development of depression in adolescence. Indeed, there
is a critical gap of knowledge on the impact of PCBs on depression. The present application is intended
to close this gap using adolescent mouse models. The central hypothesis of this proposal is that PCB
exposure in adolescence primes for depression. Mechanistically, we will focus on the gut microbiome-
brain axis because of the evidence that gut bacteria influence depression and exposure to PCBs induces
both the gut dysbiosis and dysfunction of the blood-brain barrier (BBB). We propose the following
sequence of events, which will be studied in mouse models chronically exposed to PCBs: gut dysbiosis
and disruption of the gut barrier (Aim 1) → dysfunction of the BBB and neuroinflammation (Aim 2) →
development of depressive syndromes (Aims 1 and 2). Our translation objective is to demonstrate that
exposure to a human-relevant PCB mixture contributes to, and accelerates, the pathomechanisms of
depression via the gut microbiome-brain axis and chronic brain neuroinflammatory responses. The
significance of our proposal is in its focus on leading public health problems in the US, namely depression
in adolescents. The impact of PCBs on the development of depression is largely unknown, making the
proposed studies innovative and likely to generate unique data sets. The discoveries resulting from this
proposal are expected to have significant epidemiological, economic, and social implications. Knowledge
of the underlying mechanism(s) whereby PCBs prime individuals to depression may provide novel targets
for pharmacological intervention. As such, outcomes of this application will close a crucial knowledge gap
and provide critically important and therapeutically relevant information on the involvement of
environmental toxicants in the development of depression in adolescents. Our long-term goal is to
characterize how environmental exposures contribute to the pathomechanisms of depression in
adolescents and, ultimately, prevent its development through a precision environmental health
intervention.

Public health relevance
PROJECT NARRATIVE There is a critical and emerging gap of knowledge on the impact of environmental factors on the development of psychiatric diseases, including depression. The central hypothesis of this proposal is that exposure to polychlorinated biphenyls (PCBs) in adolescence primes for depression. This hypothesis will be evaluated in the context of the gut microbiome-brain axis because of the evidence that gut bacteria influence depression and other psychiatric disorders and exposure to PCBs induces both the gut dysbiosis and dysfunction of the blood-brain barrier (BBB).